Phase I STTR: Targeting substrate of gamma-secretase for selective amyloid reduction in Alzheimer’s Disease

Amyloid plaque is a pathological hallmark of Alzheimer’s disease (AD). The inhibition of g-secretase to reduce
amyloid load has been a prominent strategy in AD drug discovery, but clinical trials of g-secretase inhibitors
failed due to side effects and worsening memory deficits in patients. In an effort to circumvent these problems,
we will carry out drug discovery that targets the transmembrane domain of the amyloid precursor protein
(APPTM), which is the substrate of g-secretase. The long-term goal is to create drugs that selectively reduce
amyloid production for disease-modifying treatment of AD. In this proposal, we will first carry out SAR of C1
and lead optimization based on both drug activity and in cellulo ADME(aim 1); then we will carry out In vivo PK
and PD studies to characterize pre-clinical candidates (aim 2).

Public health relevance
Alzheimer’s disease (AD) is one of the most serious challenges to public health in US. In this Phase I STTR, we will carry out drug discovery against a novel and challenging target for amyloid reduction in AD, the transmembrane domain of APP (APPTM) by optimizing an existing inhibitory compound C1 to prove feasibility for developing preclinical candidates. The results will open a novel direction for a cure for AD and prepare our small business AlphaMemory, LLC for Phase II STTR.